Lung cancer screening for Veterans: measuring real-world benefit and harms

Background: Two randomized trials demonstrated that lung cancer screening (LCS) prevents lung cancer
death: the National Lung Screening Trial (NLST) and the Nederlands–Leuvens Longkanker Screenings
Onderzoek (NELSON) trial. LCS-eligible Veterans have three times as many comorbidities as trial participants.
Risks/benefits of LCS outside of healthy trial participants are unclear. National guidelines including those of the
VA consistently emphasize screening only those in good health yet disagree on how to identify them. My early
research shows that, in current VA practice, Veterans in poor health are screened for lung cancer despite lack
of proven benefit for them. This exposes Veterans to the harms of screening without likely benefit. Scientific
Rationale: We lack an understanding of real-world benefits of LCS across the spectrum of health. Veterans,
clinicians, and the VA need precision estimates of the risks/benefits of LCS, tailored to individual health. To
address this critical knowledge gap, this project will create two cohorts to examine the effectiveness of LCS as
currently used in the VA, and identify pre-screening health metrics that predict benefit from LCS.
Specific Aims: Aim 1A. To examine the effectiveness of LCS as currently used in the VA in shifting lung
cancer to an earlier stage at diagnosis. Aim 1B. To identify the threshold of health at which LCS is beneficial in
terms of stage shift. Aim 2A. To examine the effectiveness of LCS as currently used in the VA in reducing lung
cancer death. Aim 2B. To identify the threshold of health in which LCS is effective in preventing lung cancer
death. Exploratory analyses will examine how the benefit of LCS varies by race/ethnicity and sex.
Methods: In Aim 1A, I will create a national cohort of Veterans using MVP data and test whether screening
favorably shifts the stage at lung cancer diagnosis. I will apply propensity methods, survival analysis, and novel
target trial methods to determine the effectiveness of current use of LCS in the VA (i.e., without regard to
baseline health) in reducing advanced lung cancer. In Aim 1B, I will examine whether NELSON eligibility
criteria (good/excellent self-rated health and/or can climb stairs) identify Veterans who benefit from LCS in
terms of stage shift. In Aim 2A, I will create a national cohort of Veterans using Corporate Data Warehouse
(CDW) data. I will use the same methods as in Aim 1A to measure LCS’ effectiveness to reduce lung cancer
death in currently VA practice. In Aim 2B, I will examine whether LCS reduces lung cancer death among those
with Care Assessment Needs (CAN) score≤60 (i.e., in similar overall health as NLST trial participants) or with
life expectancy>5 years (VA’s recommended threshold of health before LCS, based on expert opinion).
Innovation: This proposal is conceptually innovative: I will (1) determine the real-world effectiveness of LCS,
(2) test whether health metrics predict benefit of LCS, and (3) utilize health metrics relevant to Veterans and
LCS. This proposal is methodologically innovative: I will apply novel target trial methods to estimate LCS’
effectiveness in those who would/would not have qualified for trial inclusion due to health and use MVP data.
Significance/Impact: The current project directly responds to CSR&D priorities to obtain an in-depth
understanding of disease processes that are highly relevant to Veterans and will generate clinically relevant
deliverables to test in subsequent independent work. Lung cancer kills more Veterans than any other cancer.
1.8 million Veterans are eligible for LCS, but screening is reaching Veterans who are least likely to benefit due
to poor health. This project’s central research objective is to generate precision estimates of benefits of LCS
stratified by health. In the future, these estimates will be applied to design decision support tools that promote
screening among those likely to benefit. My training objectives are to become experienced with the use of VA
data for research, gain a rich skillset of rigorous quantitative methods, develop LCS content expertise, and
form partnerships with VA leaders in the field. The skills, experience, and relationships I gain from this work will
support my goal of being an independent VA investigator focused on preventive interventions for Veterans.

Public health relevance
Lung cancer screening (LCS) can prevent lung cancer death. LCS-eligible Veterans are less healthy than participants in randomized trials of LCS. Thus, we cannot extrapolate from LCS trials to predict benefit of LCS among Veterans. Veterans in poor health are unlikely to live to see an averted lung cancer death, but in current VA practice LCS is common among Veterans in poor health. This project will determine real-world benefits of LCS as practiced in the VA and deliver detailed estimates of benefits of LCS among Veterans across the spectrum of health. The results of this project will inform providers and VA policy makers on whom should be targeted for LCS to avert harms from screening. This information is necessary to create decision support tools that present personalized estimates of LCS’ benefit tailored to individual health in future projects. Moreover, it will support the skills and experience needed to launch my career as a VA investigator focused on preventive health interventions for Veterans.